JAX MorPhiC Data Production Center

PROJECT SUMMARY
This proposal will establish a Molecular Phenotypes of Null Alleles in Cells (MorPhiC) Phase 1: Data Production
Research and Development Center based entirely at The Jackson Laboratory for Genomic Medicine – the JAX
MorPhiC Center. JAX MorPhiC will comprise, under one roof, a team of highly collaborative scientists with
complementary skill sets and decades of cumulative experience in mammalian gene knockouts (KO), stem cell
and developmental biology, molecular phenotyping, single cell analysis, and advanced metabolomics and
lipidomics capabilities. We will KO 250 protein-coding genes over the Phase 1 period of this initiative and will
engineer these KOs in human induced pluripotent stem cells (iPSCs) that will subsequently be differentiated into
two cell lineages, the extra-embryonic and the neuroectodermal, where cells will then be comprehensively
phenotyped. Our rationale for selecting these lineages is that they are two of the most evolutionary divergent
between species, and primate-specificity is one of our criteria for gene prioritization. In addition, the extra-
embryonic lineage rapidly develops into a cellular functional endpoint responsible for many biological processes,
thus permitting interpretation of function of diverse genes, whereas the early neuroectodermal lineage is relevant
to neurodevelopmental disorders. In Aim 1, we will prioritize genes for knockout; selection criteria include
expression in extra-embryonic or neuroectodermal lineages, primate-specific features, broad classes of
functions while enriching for transcription factors, and genes implicated in human disease. In Aim 2, we will
generate iPSC KO clones in high-throughput using high-efficiency protocols and workflows established in JAX's
Cellular Engineering core. We will engineer KO clones for 250 genes in the well-characterized, stable human
iPSC line, KOLF2.1, while considering the effects of sex, genetic background, possible adaptive/compensatory
responses, and different KO strategies including incorporation of conditional/reversible and scalable approaches.
In Aim 3, will carry out comprehensive phenotyping of derivatives differentiated from KO iPSCs. We have
selected a combination of assays to maximally integrate consistency, scalability, and functional informativeness
to help achieve the overall objectives of the MorPhiC Consortium. These include imaging, single cell
transcriptomics, single nucleus epigenomics, and metabolomics/lipidomics. Our research Aims will be
coordinated in administrative Aim 4, which will ensure efficient project management and oversight, internal and
external communications, and data dissemination to the MorPhiC Data Resource and Administrative
Coordination Center (DRACC). Successful completion of the proposed work will address several main barriers
hampering the ultimate goal of the MorPhiC Consortium to functionally characterize all human genes: identifying
the most effective KO strategies and optimal phenotyping technologies, as well as scaling efficiencies to expand
this program towards future MorPhiC Phases. In the process, we will generate a valuable resource of 250 human
iPSC KO lines that will be distributed to the scientific community via existing operational infrastructure at JAX.

Public health relevance
PROJECT NARRATIVE Knowledge of the function of every human gene is necessary for determining the roles and relationships of genes and regulatory elements in various normal and disease-associated biological pathways and networks. In this project, we will leverage the state-of-the-art cellular engineering and single-cell capabilities of The Jackson Laboratory to comprehensively catalog the phenotypes of 250 null mutations in human induced pluripotent stem cells differentiated into extra-embryonic and neuroectodermal lineages. By focusing on these early embryonic lineages, we will gain important insight into multiple biological processes, including neurodevelopmental disorders and those impacting later life.